Center in Molecular Toxicology

DESCRIPTION (provided by applicant): Training new leaders is a historical strength in the Vanderbilt program. The Training Program in Environmental Toxicology (T32 ES007028) is now in its 34th year of continuous funding, and a competitive renewal application was reviewed in November 2008 (currently 8 pre-doctoral and 6 postdoctoral positions, priority score 132, anticipated to be funded). Five current or former NIEHS P30 Core Center Grant Directors either trained at Vanderbilt or began faculty careers here.